Exploiting microbial regulatory networks to accelerate natural products discovery

PROJECT SUMMARY
Microbes have been a fruitful source of bioactive natural products on a broad pharmaceutical spectrum. While
traditional bioactivity-guided screening approaches have contributed to natural product discovery over the last
decades, re-discovering known molecules, laborious protocols, and low compound concentrations have
hindered substantial resource investment. The search for novel natural products has been revamped with
technological advances metagenomics, pathway prediction tools, analytical techniques, and activation of
silent biosynthetic genes using exogenous stimuli. However, non-optimal cultivation of organisms and
uncontrolled expression of biosynthetic pathways in laboratory conditions currently conceal the full
biosynthetic potential of microbial natural products. My laboratory works on developing genetic strategies for
discovery and increased production of natural products. This research project will systematically characterize
how regulatory networks control secondary metabolism, using genome-wide screens and multi-omics
approaches to predict and access the unexplored biosynthetic potential of microbes. Uncovered molecular
mechanisms will create an essential step towards the design of improved platform strains using first-principle
models. Deciphering metabolic capabilities will provide a foundation for the large-scale production of novel,
low abundant and unnatural analogues of natural products. Collectively, this research proposal has the
transformative potential to accelerate the discovery, characterization, and commercialization of
novel natural products as therapeutic leads.

Public health relevance
PROJECT NARRATIVE Microbes are an unparalleled source of natural products with complex chemical signatures and diverse bioactivities. This project aims to elucidate the regulatory mechanisms that drive the expression of secondary metabolism under laboratory conditions to guide systems metabolic engineering approaches for the discovery, characterization, development, and industrial-scale production of natural products.